Impact of prescription stimulants on the drug overdose epidemic

ABSTRACT
The use of prescription stimulants in adults has increased dramatically, with a five-fold increase in use
of amphetamines between 2004 and 2019. Coinciding with increased prescribing of stimulants, there has been
an acceleration of fatal overdoses involving illicit psychostimulants. During the COVID-19 pandemic, stimulant-
related fatal overdoses reached the highest point on record, with 20,054 fatal overdoses involving cocaine and
23,352 involving methamphetamine in 2020 alone. While it is well-established that rising rates of prescription
opioid use was associated with an increase in heroin use in turn fueling increases in fatal overdoses, it is not
yet known if rising prescription stimulant use is associated with transition to illicit stimulants and overdoses
involving illicit stimulants. This is of critical importance given high rates of fentanyl contamination in the illicit
stimulant supply and counterfeit stimulant pills obtained from illegitimate online pharmacies.
In addition to potential harmful effects, there are also some RCT’s suggesting prescription stimulants
may promote short-term abstinence in individuals with pre-existing substance use disorders. Whether these
benefits translate to reductions in overdose is unknown. The current application will fill a critical gap by using
real-world evidence to identify the consequences of prescription stimulant use on drug overdoses. Our
multidisciplinary research team will use robust real-world data sources linking prescription drug monitoring
program data, state-wide all-payer claims data, emergency medical service data, emergency department visit
and hospital discharge data, substance abuse treatment data and vital records (death certificate/toxicology) for
~ 10 million individuals from two states, Massachusetts and Oregon.
In response to the NIDA program announcement RFA-DA-22-037 “Accelerating the Pace of Drug
Abuse Research Using Existing Data, we will address three aims: 1) We will use a priori definition of high
risk use, supported by preliminary data, to define the impact of high risk prescription stimulant use on the risk
of fatal and non-fatal overdoses involving stimulants and/or polysubstance use; 2) We will assess the potential
therapeutic role of prescription stimulants in preventing drug overdoses in individuals with stimulant and opioid
use disorders; and 3) We will use group-based trajectory modeling to identify longitudinal stimulant prescribing
patterns that may aid in predicting overdose. Aim 3 complements the other aims by capturing heterogeneity in
prescribing patterns that may be associated with protective or increased risk of overdose.
Given prescription stimulants are one of the most widely prescribed classes of medications in the
United States, it is imperative to understand the risks/benefits of these medications with the overall goal of
reducing stimulant-related overdose.

Public health relevance
PROJECT NARRATIVE While a large body of research has demonstrated high risk patterns of prescription opioid use predicts overdose, the role of prescription stimulants on the drug overdose epidemic is understudied. Using novel comprehensive state-wide datasets from Oregon and Massachusetts, the proposed research will fill a critical gap by assessing the impact of prescription stimulant use on drug overdoses. By identifying prescribing patterns with protective or harmful effects on rates of drug overdoses, evidence generated from these studies could lead to changes in policy, early intervention with patients at risk of overdose, and public health initiatives such as continuing medical education activities or updated clinical guidelines that promote safe prescribing of stimulants with goal of mitigating stimulant-related overdose.